Molecular Dissection of Proprioceptor Subclass Identity

SUMMARY
The proprioceptive sense relies on multiple sensory subtypes that relay information from skin, joint, or muscle,
to best estimate changes in limb dynamics. Proprioceptive muscle afferents - arguably representing the primary
input into this sensory system – derive their sensory feedback information from two specialized mechano-
receptive end-organs in skeletal muscle: muscle spindles (MSs), and Golgi tendon organs (GTOs). These end-
organs respond to changes in muscle length or tension, respectively, and this information is routed to spinal and
supraspinal motor centers through MS-groups Ia and II afferents, and GTO-group Ib afferents, which each relay
qualitatively distinct features of limb state (e.g., movement speed, position, effort). The combined afferent
feedback is used by central somatosensory and motor circuits to compute changes in limb state during passive
or voluntary movement, and to correct the motor plan if needed.
Despite their importance in movement control, how individual proprioceptor subtypes emerge during
development remains poorly understood. Two opposing ideas are considered. First, it has been postulated that
proprioceptive muscle afferent subtypes are genetically predetermined, meaning that their MS-group Ia or II, or
GTO-group Ib identity, is fixed from the moment these neurons become post-mitotic. Recent data however,
including from our lab, have led to the hypothesis that proprioceptive neurons adopt their specific subtype identity
only after they innervate their cognate peripheral receptors, possibly instructed by signals from nascent MS or
GTO end-organs or through activity-dependent mechanisms. This proposal aims to test this idea through three
parallel aims that examine intrinsic proprioceptor transcriptomic and epigenetic dynamics i) prior to and just
following end-organ innervation, ii) in the absence of extrinsic end-organs derived signals, or iii) when neural
activity is compromised.
Together, these experiments will identify the transcriptional and epigenetic signatures of proprioceptors
as they undergo their developmental transitions to assume MS- or GTO-afferent subtype identities, and provide
insight into the relevant signals that are needed to coordinate this process or to maintain these identities. The
results should lead to an expansion of the genetic and molecular tools to study proprioceptor function. Moreover,
given recent demonstrations that epidural stimulation of proprioceptive pathways benefits patients suffering from
spinal cord injury, a better understanding of the developmental cues that promote one proprioceptor subtype
over another may permit the selective stimulation/repurposing of those proprioceptor subtypes that are especially
beneficial for recovery.

Public health relevance
NARRATIVE Motor neural networks rely on distinct proprioceptive sensory inputs to optimally tune behavioral outcomes, yet how proprioceptor diversity is regulated during development remains incompletely understood. This proposal aims to perform a comprehensive analysis of the transcriptional, epigenetic, and peripheral signaling mechanisms that underlie proprioceptor subtype identity. The results of these studies will provide new insights into proprioceptor specification, lead to an expansion of the genetic and molecular tools to study proprioceptor function, and will have clinical implications for the development of new treatment strategies for spinal cord injury.